Biospecimen Core

BIOSPECIMEN CORE: SUMMARY
The Biospecimen Core is a vital resource that supports all brain tumor research at Northwestern, and is
especially important in seeing that all projects experience clinical translation within the period of SPORE funding.
Regular interactions with the Biostatistics & Bioinformatics Core and Administrative Core will ensure that each
project achieves its objectives, and has positive impact on the care of brain tumor patients.
The Biospecimen Core will have extensive interactions with all projects and cores by acting as the central
repository of patient tissues and renewable tumor resources, by providing the highest quality of tissue analytical
services, and by providing neuropathological consultation. The Director of the Core, Dr. Horbinski, as well as the
Co-Director, Dr. Daniel Brat, will supervise quality control testing of banked specimens, and will perform all
microscopy-based analyses of patient tissues and tumor models for each SPORE project. Biospecimen Core
activities will be performed to accomplish the following aims:
Aim 1: Provide Northwestern brain tumor researchers with annotated biospecimens from patients.
Aim 2: Subject all biospecimens to rigorous quality control.
Aim 3: Conduct biospecimen-based independent research to study brain tumor biology and optimize the
use of clinically relevant biomarkers.
Aim 4: Support SPORE projects with biospecimens and neuropathologic analyses.

Public health relevance
BIOSPECIMEN CORE: NARRATIVE The Biospecimen Core will serve as source of patient tumor and normal tissues to meet the needs of the individual projects. The Core also generates its own biospecimen-based research pertaining to brain tumors, and will provide all tissue and tumor model analytical services that are needed to advance SPORE laboratory and clinical research.